Cellular Imaging Core (CIC)

ABSTRACT
The Cellular Imaging Core (CIC) plays a pivotal role in the multidisciplinary research pipeline of IDDRC
investigators at Boston Children’s Hospital and Harvard Medical School. Located within the Kirby Neurobiology
Center of Boston Children’s Hospital, this shared microscopy facility offers researchers access to high-end and
specialized microscopy and digital imaging approaches which they can harness to understand the underlying
mechanisms and structural changes associated with neurodevelopmental disorders. The Core offers widefield,
confocal (multiphoton, laser-scanning, spinning disk) and super-resolution (stimulated emission depletion,
STED) microscopes for high resolution subcellular localization of proteins of interest, for tracking live cells over
prolonged periods of time, and for monitoring populations of cells in vivo in an awake, behaving animal. These
instruments are accompanied with access to image analysis workstations, and importantly, to an extensive
educational program that trains researchers one-on-one on the capabilities and limitations of each instrument
and software package used. Core staff can also collaborate closely with IDDRC researchers in core-assisted
projects to design, optimize and implement custom designed experiments or analysis approaches. Additionally,
the Core offers Instrumentation and Technology Courses to inform the scientific community about what is new
for state-of-the-art microscopy, to provide interactive, hands-on workshops on image acquisition, analysis and
processing and to address issues in robustness with these imaging methods. Through these interactions with
researchers, the Core identifies and obtains new equipment and technology that is relevant to our researchers.
Taken together, here the CIC proposes a comprehensive program of collaboration with IDDRC investigators
and other IDDRC Cores to lower the barrier for laboratories to incorporate novel and transformative
microscopy technologies that elevate and accelerate our understanding of normal and pathological neural
development, plasticity and function.